Wireless, Closed?loop System to Restore Urological Dysfunction after Spinal Cord Injury

PROJECT SUMMARY
Many (>70%) individuals that suffer a severe, high-level spinal cord injury (SCI) develop bladder detrusor
sphincter dyssynergia (DSD). A substantial number of these individuals will develop serious urological
complications such as urinary tract infection, renal reflux effect, or renal failure. Current treatments are limited
and the complications rates can be significant using stent implantations or other surgical procedures. Thus,
development of new tools/therapies that help stimulate more reliable/efficient bladder emptying could
significantly improve quality of life and the overall health of SCI patients. The overall objective of the project is to
develop a wireless, battery-free implant capable of supporting artificial intelligence (AI) algorithm for autonomous
closed-loop neuromodulation (CL-NM) management of DSD after SCI. We will fabricate and validate a wireless,
battery-free bioelectronic implant that allows continuous, long-term monitoring and autonomous electrical
stimulation through a closed-loop AI system. We will also demonstrate closed-loop neuromodulation (CL-NM)
treatment of detrusor sphincter dyssynergia (DSD) in rat SCI model. The soft stretchable electrodes with high
charge injection capability will be able to stimulate the acute and sub-acute bladder wall to induce detrusor
contraction, while simultaneously fatiguing the EUS and PFMs to reduce outflow resistance. Such a combination
effect will result in a near normal voiding process. The proposed bioelectronic system will have broad clinical
utility in monitoring and modulating bladder function, and provide a new treatment method together with closed-
loop technologies for patients with severe DSD that do not respond to traditional therapies. This technology
platform can also be easily adapted to address a range of application possibilities beyond those associated with
the bladder. It will have significant impact in field of Rehabilitation and regeneration after SCI.

Public health relevance
PROJECT NARRATIVE This project will focus on developing a novel and advanced urological technology to improve the coordination between bladder and sphincter functions in neurogenic bladder patients. The developed bioelectronic platform will have broad clinical utiltiy in monitoring and modulating bladder functions, and provide a new treatment paradigm for SCI patients with detrusor sphincter dyssynergia in lieu of rather ineffective traditional therapies. 1